Implementation of a Medication Adherence Instrument among Patients with Symptomatic Peripheral Artery Disease after Peripheral Vascular Intervention

Peripheral artery disease (PAD) affects roughly 12 million Americans and accounts for over $21 billion in
combined annual healthcare costs. Patients with PAD are at an increased risk of future cardiovascular events,
including amputation, myocardial infarction, and death. Patients with PAD who undergo a peripheral vascular
intervention (PVI) for claudication symptoms or for lower extremity ulcers or gangrene have a guideline-based
indication to be on multiple evidence-based medications. These medications include high intensity statins,
aspirin, a P2Y12 inhibitor (clopidogrel), and an angiotensin-converting enzyme (ACE) inhibitor or angiotensin
receptor blocker (ARB). Adherence to these medications after PVI can significantly reduce the future risk of
amputation, myocardial infarction, and/or death. However, observational data of patients with PAD after PVI has
demonstrated poor medication adherence to these evidence-based medications. Additionally, there has been
no prior examination of the barriers and facilitators of medication adherence in this population of patients.
Moreover, there is little evidence regarding strategies to improve medication adherence in this vulnerable
population of patients. This proposal seeks to identify the barriers and facilitators of medication adherence in a
population of patients with PAD who have undergone PVI, and to develop a medication adherence tool to
promote discussion of and mitigation of barriers to adherence in the outpatient clinic environment. In Aim 1, we
will conduct semi-structured interviews of 40 patients with PAD who have undergone PVI to examine barriers
and facilitators of medication adherence. In Aim 2, we will then use evidence-based quality improvement
methods and a diverse research engagement panel, consisting of providers, patients, nurses, and experts in
information technology, to develop a medication adherence tool for use in the outpatient clinic. This tool will be
integrated into the electronic health record and will facilitate discussion of barriers to adherence and potential
strategies for improving adherence. In Aim 3, we will perform a pilot feasibility randomized controlled trial of 200
patients in two sites within the Duke Health System to examine the feasibility and acceptability of the adherence
tool, as well as the effect of the intervention on rates of medication adherence. This pilot randomized controlled
trial will establish the foundation for a future, multi-center randomized controlled trial examining the use of the
tool to improve rates of adherence and clinical outcomes. This research will occur in the setting of a
comprehensive career development program designed to provide Dr. Rymer, an interventional cardiologist and
a vascular proceduralist, with the training, experience, and leadership development needed to become an
independent clinical research investigator. During the award period, Dr. Rymer’s team of exceptional mentors
will guide her to develop expertise in qualitative research, implementation science, and clinical trial design. Dr.
Rymer’s long-term goal is to improve the health of patients with PAD who have undergone an intervention by
achieving optimal adherence to guideline-directed medical therapies.

Public health relevance
For patients with peripheral artery disease (PAD) who undergo a peripheral vascular intervention (PVI) to improve quality of life and/or prevent limb loss, there are evidence based, guideline-directed medical therapies that should be prescribed after the intervention. However, adherence to these therapies remain poor among this population of patients, placing them at an increased risk of limb loss, cardiovascular disease, and death. The proposed work leverages complementary methods in qualitative research, implementation science, and clinical trial design to examine the barriers to medication adherence and evaluate a potential tool that may facilitate improved communication between the clinic provider and patient about how to improve adherence to these therapies in patients with PAD who have undergone PVI.